Effects of a non-nutritive sweetener reduction intervention in pregnancy and lactation on maternal and infant outcomes (the SWEETPEA trial)

ABSTRACT
Increasing evidence demonstrates that suboptimal conditions in the womb, including poor maternal nutrition,
contributes to obesity and cardiometabolic disease risk. One potential contributor to poor maternal nutrition is
chronic consumption of non-nutritive sweeteners (NNS). Studies indicate that approximately 30% of pregnant
women and 44% of lactating women in the United States regularly consume NNS. However, a growing body of
evidence demonstrates that NNS consumption is paradoxically associated with obesity and metabolic risk
factors. While effects of NNS consumption during pregnancy and lactation on maternal and infant metabolic
health are not well understood, the available evidence suggests cause for concern. For example, NNS
consumption during pregnancy increases maternal blood sugar and induces fetal hypoglycemia and growth
restriction in mice – both of which are risk factors for offspring obesity. Further, three prospective cohort studies
in humans have reported an association between maternal NNS consumption and childhood weight or adiposity,
although another found no relationship. Our own pilot data indicate that NNS consumption during pregnancy
increases infant fat mass and disrupts the infant gut microbiome at 1 month of age. However, the limited,
contradictory, and observational nature of the human evidence collected to date has made it difficult to establish
guidelines around NNS consumption during pregnancy. We therefore propose the first randomized controlled
trial (RCT) to examine the effects of NNS during pregnancy and lactation. We will recruit 324 pregnant women
who frequently consume NNS (≥7 servings/week) and examine the effects of NNS restriction on maternal and
infant metabolic outcomes. Pregnant women will be randomly assigned to one of three groups: 1) no NNS
restriction (control); 2) NNS restriction during lactation only; and 3) NNS restriction during pregnancy and
lactation. The intervention will consist of monthly consultations with a dietitian to provide counseling on
replacement of NNS consumption with unsweetened food and beverage alternatives and home delivery of such
alternatives. Adherence will be assessed via 24-hour dietary recalls and by objectively measuring NNS
concentrations in urine and breast milk. Our primary aims will be to determine the effects of NNS-restriction on:
1) infant body composition at 1 and 6 months of age; 2) maternal glucose tolerance at 24-28 weeks’ gestation;
and, 3) infant gut microbiome and fecal metabolites at 1 and 6 months of age. We hypothesize that NNS
restriction among pregnant women who habitually consume NNS during pregnancy and/or lactation will reduce
infant fat mass (compared to a no NNS restriction (usual NNS intake) control group), via improvements to
maternal glycemia and the infant gut microbiome and metabolome, with the greatest benefit in the pregnancy
and lactation group. This research could shape recommendations around NNS consumption during pregnancy
and lactation, thereby potentially reducing the global burden of obesity and cardiometabolic disease.

Public health relevance
PROJECT NARRATIVE The effects of consuming non-nutritive sweeteners (NNS) during pregnancy and lactation on infant obesity and cardiometabolic disease risk are not well understood. In this project, pregnant women who frequently consume NNS will be randomly assigned to an NNS-restriction intervention (NNS restriction during pregnancy and lactation or during lactation only) or a control group (no NNS restriction) to determine whether NNS consumption during pregnancy and/or lactation affects infant body composition, maternal blood sugar during pregnancy, and the infants’ gut microbiome and metabolome. The results of this study have the potential to shape recommendations around NNS consumption during pregnancy and lactation, thereby potentially improving maternal and infant metabolic health and reducing the global burden of obesity and cardiometabolic disease.